Ultrasensitive multiomic platform using epitope-targeted DNA methylation mapping

PROJECT SUMMARY
Gene expression is regulated by the complex molecular cross-talk between DNA methylation (DNAme)
and other chromatin features: e.g. histone post-translational modifications (PTMs) and chromatin associated
proteins (ChAPs; transcription factors and chromatin remodelers). Significantly, changes in the chromatin
landscape can have a profound impact on DNAme patterning (and vice versa), and these changes are connected
to development as well as a broad range of diseases (from cancer to neurological disorders). However, our
understanding of how DNAme co-occurs / coordinates with additional chromatin features to control gene
expression is limited by a lack of reliable genomic tools. Here, EpiCypher is partnering with New England Biolabs
(NEB) to develop Targeted Enzymatic Methylation-sequencing (TEM-seqTM), an ultra-sensitive multiomic
mapping technology that delivers high resolution DNAme profiles (5mC/5hmC) at epitope-defined
chromatin features. EpiCypher is leading the development of ultra-sensitive genomic mapping assays that use
CUT&RUN / CUT&Tag methods (under the CUTANA® platform) to generate truly quantitative data using
dramatically reduced cell input and sequencing depth (>10-fold savings on each parameter vs. ChIP-seq).
CUTANA assays are supported by EpiCypher’s proprietary spike-in designer nucleosome (dNuc) technology to
enable technical monitoring and quantitative normalization. The key innovation of the TEM-seq project is the
development of a novel multiomic workflow that marries EpiCypher’s quantitative CUTANA CUT&RUN
technology with unbiased DNAme analysis using NEB’s enzymatic methyl-seq (EM-seq) approach. EM-seq
utilizes the enzymatic conversion of DNAme (5mC / 5hmC) and provides a much-needed alternative to bisulfite
sequencing (BS; a chemical treatment that degrades DNA and has systemic sequence biases) to generate high
resolution, unbiased DNAme profiles with ~10-fold less sample input (vs. BS). In Phase I Aim 1, we will rigorously
validate our TEM-seq workflow in three cell lines, benchmark results against standard CUT&RUN and EM-seq
assays, and further develop EpiCypher’s spike-in controls for compatibility with TEM-seq. We will advance to
Phase II when we demonstrate that TEM-seq generates highly reliable DNAme maps associated with histone
PTMs and ChAPs using <50k cells and <10M reads. In Phase II Aim 2, we will expand development of spike-in
control panels and develop robust protocols for a wide panel of chromatin features (using validated antibodies)
and sample processing methods (fresh, frozen, and fixed), including drug treatment time-course experiments to
enable clinical applications. In Phase II Aim 3, we will develop / validate a TEM-seq beta kit, and also create a
data analysis portal and automated assays to accelerate commercial adoption and enable a high-throughput
service offering. TEM-seq will provide a powerful new tool to expand our understanding of complex chromatin
signaling, further unlocking the potential of epigenetics-targeted drugs and diagnostics.

Public health relevance
PROJECT NARRATIVE Gene expression is regulated by the integration of DNA methylation (DNAme) and other chromatin features, including chromatin accessibility, histone post-translational modifications (PTMs), chromatin remodelers, and transcription factor binding. However, our understanding of how DNAme co-occurs (and coordinates) with these features to control gene expression is limited by a lack of reliable genomic tools. Here, EpiCypher is partnering with New England Biolabs (NEB) to develop an ultra-sensitive multiomic mapping technology that delivers high resolution DNAme (5mC/5hmC) profiles at defined chromatin features, providing a powerful new approach to advance our understanding of chromatin regulation and unlock the full potential of epigenetic-targeting therapeutics and diagnostics.